IDENTIFYING ISSUES AND OPTIONS TO UNDERSTANDING TANF-COMPATIBLE OUTCOME MEASURES FOR EMPLOYMENT SERVICES (OUTCOMES)

This project will explore the issues and options related to the development of an employment-related outcome performance measurement system for the TANF program, including potential target groups, performance measures, performance standards, data needs, and accountability approaches. The project will also make recommendations on ways to improve the coordination between TANF and Workforce Innovation and Opportunity Act (WIOA) performance measurement systems. The study is being conducted by the Urban Institute.